FY22 COMMUNICATION SUPPORT FOR DCCPS

The purpose of the call order is to provide web-based, online, electronic and other communication support as well as outreach that enables DCCPS more effectively interact with stakeholders by sharing important information about the DCCPS research portfolios and the resulting tools, products, and scientific advances. These stakeholders include a wide range of constituents such as the extramural research and scientific community, NIH and Department leaders, scientific advisory boards, consumer liaisons, Congress, partner organizations within and outside government, cancer advocates, cancer survivors, and the public. One important outreach via this SOW and Task is with Strategic Health Concepts for support to the Comprehensive Cancer Control National Partnership. Likewise, expanded support for the SBIR program, dissemination support for research and grant programs, and the translation and packaging of research findings into education and communication tools for the public health and research communities.